Eye Movements, Gaze Correction, and Visual Short-Term Memory

[unreadable] DESCRIPTION (provided by applicant): People make tens of thousands of saccadic eye movements each day, and a substantial proportion of these fail to land on the intended object. To be efficient, the visual system must rapidly correct these errors and make a corrective saccade to the intended object. Previous research has shown that gaze correction is fast and automatic under simple laboratory conditions, in which only a single object is present. In the natural world, however, there are many possible gaze targets, and determining which object was the original saccade target will often require the use of a memory representation of the target object. However, no previous studies have attempted to demonstrate that memory is used to correct saccade errors. In the proposed research, we plan to show that memory for the saccade target is indeed used to correct saccade errors, and that these corrections are fast, accurate, automatic, and perhaps even unconscious. Our central hypothesis is that visual short-term memory (VSTM) stores target information across the saccade so that the target object can be discriminated from other visible objects and gaze can by efficiently corrected. To test this idea, we developed a new paradigm to simulate saccade error, in which a stimulus array is shifted slightly during a saccade so that the eyes land between the target object and a distractor object. Our preliminary results suggest that memory-based gaze correction under these conditions is accurate, fast, and automatic. The proposed work will explore the nature of the memory representations used for these gaze corrections, including (a) testing whether the memory representations are stored in VSTM, (b) examining what information is stored in these representations, (c) exploring how these representations are combined bottom-up sensory information, and (d) determining whether the representations include information about other nearby objects. These studies will advance our understanding of basic mechanisms of gaze correction that support efficient interaction with objects and agents in the world. Most complex visual tasks (preparing food, driving) depend on fixating a series of objects, and gaze correction plays an important role in ensuring that the eyes are directed efficiently to goal-relevant objects. Thus, the proposed research will provide essential information for understanding conditions that involve deficits in the control of gaze. [unreadable] [unreadable] [unreadable]